Human Phenotyping Core

ABSTRACT - CORE B The Human Phenotyping Core component of this PPG will provide the clinical liaison, expertise and organization necessary to accomplish the studies involving human subjects that are proposed in the projects within this PPG. The Core will be responsible for subject recruitment and accurate phenotyping as-well-as clinical specimen collection, clinical data acquisition and subject follow-up. The Human Phenotyping Core will interact intimately with the other Cores to ensure distribution of clinical samples and data to Program investigators. In this capacity, the Phenotyping Core will function as a collective resource to the PPG that will facilitate accomplishment of each of the four Projects and also promote interaction between the different Projects to glean the most information from valuable clinical samples.

Public health relevance
NARRATIVE - CORE B The Human Phenotyping Core component of this PPG will provide the clinical expertise in recruiting the appropriate individuals for the research projects and obtaining and sharing the human samples necessary to conduct the research. Thus, the Phenotyping Core will function as a collective resource to the program that will facilitate accomplishment of each of the four Projects and also promote interaction between the different Projects to glean the most information from valuable human clinical samples.